Mapping inter-cellular trophoblast-decidual signaling to its effects on invasion related maternal-fetal diseases

Abstr act
Certain invasion-related maternal-fetal diseases (IMFDs) occur due to either insufficient or excessive
placental invasion into the endometrium. These are serious conditions, sometimes requiring surgical
interventions including hysterectomies, and leading to symptoms including fetal growth restriction and
preeclampsia. Previous work from the mentor (Kshitiz, UConn Health) and collaborators (Profs. Levchenko
and Gunter, Yale) studying the evolutionary history of diverse placental phenotypes has established the
central role of the endometrial stromal fibroblasts (ESFs) in controlling the extent of the invasion. The
proposed training and research plan will allow me to study the molecular basis of the endometrial stromal
control of placental invasion, including the effect of ESF-trophoblast signaling on this regulation, as I gain
the training and experience needed to launch my independent research career. During the K99 phase, my
previous training and experience in bioinformatics and computational biology will be augmented by
training from my mentor in the systems biology approach, constituting a closed loop methodology
combining phenotypic assays, theoretical modeling, experimental validation, hypothesis refinement
feeding back into experimental investigations. Exploiting the apposite model of the regulation of placental
invasion in eutherian mammals to understand IMFDs, I have since mathematically mapped and
experimentally validated the genomic basis of this variation in depth of placental invasion through specific
regulatory molecules such as GATA2 and TFDP1. Further, I found evidence that stromal invasability genes
could be conserved across tissue types, with congruent effects between placental invasion in ESFs and
melanoma invasion into skin fibroblasts. This opens avenues for delineating the molecular mechanisms of
ESF-trophoblast signaling effects on the stromal regulation of invasion, with likely parallel mechanisms
underlying dysregulated invasion in IMFDs. Using bioinformatics, bioengineered assays, mathematical
modeling I found and validated the effect of IL11s secreted by extravillous trophoblasts (EVTs) on the
decidual ESF invasability and MMP1 production through SOCS3. I will also explore how different
subpopulations within the human endometrium interact with the invading EVTs, and the downstream
signaling effect of this interaction. All molecular components identified by these methods will be validated
on a bioengineered in-vitro stromal invasion assay, functionally advanced by me, to map the stromal
genotype to specific invasion related sub-characteristics. Another microfabricated technology platform, that
I co-developed with the mentor will be augmented to infer the sequential EVT-ESF paracrine cross-talk .
During my R00 phase I will build informatics-mathematical models to predict IMFD outcomes by
integrating models from my two K99 aims with deep analysis of patient sample ESF sequencing data

Public health relevance
Project Narrative Many serious complications associated with pregnancy, like placenta accreta or placental insufficiency, happen when the placenta from the baby either grows too deep, or too shallow into the mother’s uterus posing serious risk to the mother’s life. I will study the how the cells from the fetus and the mother “talk” to each other, controlling how deeply the placenta attaches, to find ways to limit these complications without surgery.